A 26-week rat toxicity study and efficacy and biomarker studies in Tau-APP Alzheimer's mouse model to support a Phase 1b clinical study

PROJECT SUMMARY: This R44 application is focused on preparations for a phase 1b clinical study to look
for early clinical signs of efficacy/proof-of-concept by evaluating the response to treatment of relevant serum
and CSF biomarkers in a double blinded study of patients with Alzheimer’s Disease. The proposed work is
designed to support longer term dosing required to see an effect on biomarkers. The prevalence of AD is
increasing worldwide. There remains an urgent need for disease modifying drugs for AD that are cost-effective
and easy to administer. This program is progressing to fill the need with an economical, disease-modifying
drug that is stable, oral, and can be self-administered. If successful, it will have a tremendous impact on the
more than 6.5 million Americans who currently have AD (projected to be 12.7 million by 2050) and their
caregivers, and will help reduce the current cost of $321 billion (projected to be $1 trillion by 2050) to our
nation (Alzheimer's Association 2022 Alzheimer's Disease Facts and Figures). We have now completed all
preclinical work for our IND application to FDA for our first-in-human phase 1a study. A summary of this work
follows: TO-0582 demonstrated pharmacologic activity in two mouse models of tauopathy (the htau model that
has human tau with all 6 isomers best representing tau aggregation in AD and in the JNPL3 mouse model that
has a P301L mutation and represents four-repeat tauopathies), reasonable pharmacokinetic characteristics,
minimal DDI potential, lack/minimal effects on cardiovascular, pulmonary and CNS systems, and a lack of
genotoxicity. Relatively modest, non-adverse toxicity was observed in 28-day rat and dog GLP toxicity studies.
The no adverse effect level for both the rat and dog 28 day studies were the highest dose tested. Thus, TO-
0582 is an excellent candidate for clinical development for treatment of neurodegenerative diseases.
Manufacture of kilogram quantities for non-clinical safety studies (NCSS) and drug pre-formulation work has
been completed. A GMP batch was also prepared for the manufacture of our drug product OLX-07010. We are
preparing our electronic IND application for our phase 1a study that will be submitted to FDA by mid-April 2022
and anticipate first-in-human studies will begin in June of 2022. The Aims of the proposed program are: Aim 1
Perform 26-weeks oral toxicity study (GLP) in Rats with a four-week recovery period (GLP). This
includes scaling up the manufacture of TO-0582 to 5 kg level. Aim 2: Conduct a therapeutic therapeutic
efficacy study in TAPP mice; and Aim 3: Conduct an acute therapeutic efficacy study TAPP mice. The
second and third Aims will evaluate biomarkers that could translate into the planned Phase 1b clinical AD study
and to show efficacy of the compound in a mouse model with tau and amyloid beta pathology, acute and
chronic dosing studies will be performed in the tau-APP (TAPP) mice which will support transition of clinical
work from healthy volunteers to patients. As the National Institute on Aging is the primary Federal agency for
AD research, the development of a DMT for AD, has the highest relevance for its mission.

Public health relevance
PROJECT NARRATIVE There is a critical unmet need for a disease-modifying drug for Alzheimer’s disease (AD); of the ten leading causes of death in the United States, only AD cannot be prevented, slowed or cured and is increasing in incidence. This program is highly important because it is designed to fill this need with a disease-modifying drug that, if successful, will have a tremendous impact on the more than 6.5 million Americans who currently have AD (projected to be 12.7 million by 2050) and their caregivers, and will also help reduce the current cost of $321 billion (projected to be $1 trillion by 2050) to our nation (Alzheimer's Association 2022 Alzheimer's Disease Facts and Figures). This R44 application is focused on conducting 26 week GLP safety studies, and in vivo efficacy studies with translatable biomarker characterization to support a planned Phase 1b clinical study in AD patients designed to provide an early signal that the drug may be effective.